Sex Differences in E-Cigarette Flavor Sensory Perception As It Relates to Appeal and Reinforcing Efficacy Among Adult Smokers

Project Summary Female cigarette smokers have been shown to be more sensitive than males to non-nicotine sensory cues, which may explain lower rates of smoking cessation and lowered response to nicotine replacement therapies among females. Additionally, evidence suggests females have higher use of non-tobacco e-cigarette flavors and value flavor availability. This proposal seeks to elucidate how sex may influence the sensory perception of the popular e-cigarette flavor components, sweetness and cooling, and how this impacts appeal and reinforcing efficacy. We plan to examine sensory perception, appeal, reinforcing efficacy of three e-cigarette flavors (sweet flavor, cooling flavor, and unflavored) in an e-cigarette with moderate nicotine concentration when presented alone (Aim 1) and concurrently with or without nicotine (Aim 2). We hypothesize that compared to an unflavored e- cigarette liquid, sweet and cooling flavor components will be generally rated as more appealing and reinforcing among both males and females, but females will have more pronounced differences in appeal and reinforcing efficacy of sweet and cooling flavors compared to the unflavored e-liquid (Aim 1). Additionally, we hypothesize that males compared to females will work harder and demonstrate greater abuse liability for nicotine containing menthol e-liquids in when concurrently available with menthol e-cigarettes with no nicotine (Aim 2). The outcomes of this project will provide new information about how the difference in response by sex to the non-nicotine sensory cues of flavor inform e-cigarette use and behavior. Regulatory efforts to restrict popular flavor components, like sweet and/or cooling flavors in e-cigarettes may have potentially a greater impact on female cigarette smokers than males on use of e-cigarettes as a potential harm reduction tool. Through expert mentoring, directed readings, formal coursework and seminars, direct experimental training, attendance at scientific meetings, manuscript and grant preparation, expertise to conduct the proposed research will be gained in the following areas: (1) chemosensory psychophysics as it relates to tobacco regulatory science, (2) sex-related research as it relates to tobacco regulatory science, and (3) advanced statistical training aimed at developing data analysis techniques to investigate sex differences & flavored tobacco product use. Taken together, this research project and training plan will provide an important framework for career development in tobacco regulatory science.

Public health relevance
This study will evaluate how sex (female, male) is associated with sensory perception, appeal, and reinforcing efficacy of e-cigarette flavors in nicotine containing e-cigarettes among adult smokers. Given the low rates of cessation among female compared male smokers and its potential relationship with non-nicotine sensory cues, this proposal will elucidate the role that perception of popular flavor components (sweet, cooling) plays in e- cigarette use, behavior, and abuse liability and how this role differs by sex. The outcomes of this project will provide the FDA with new information in key areas (Behavior, Addiction) to inform potential sex differences in response to e-cigarette flavor regulations with the aim of protecting overall public health.